Riboswitch Dynamics at Atomic Resolution

ADMINISTRATIVE SUPPLEMENT TO R01GM114432
ABSTRACT
Not applicable. There have been no changes from the parent grant.

Public health relevance
ADMINISTRATIVE SUPPLEMENT TO R01GM114432 PUBLIC HEALTH RELEVANCE Not applicable. There have been no changes from the parent grant.